Molecular insights into acute and chronic hypoxia tolerance: Investigating mechanisms of short-term plasticity and long-term genetic adaptation

PROJECT SUMMARY
Hypoxia is a condition in which the body is deprived of an adequate supply of oxygen which can
lead to severe damage to various tissues and organs and can have serious implications for the health and
well-being of the affected individual. Exposure to high altitudes is a common cause of hypoxia; populations
who permanently reside at high altitudes are exposed to chronic hypoxia, while populations only visiting
high altitudes for a short period are exposed to acute hypoxia. High-altitude human populations and certain
animal models have been extensively utilized to examine physiological changes associated with rapid
plastic responses to acute hypoxia and long-term adaptive response to chronic hypoxia. Recent genomic
studies of high-altitude human populations have provided key insights into the genetic basis of long-term
adaptation to hypoxia. E.g., genetic variations in the genes associated with hypoxia-inducible factors (HIFs)
pathways are known to play a critical role in the chronic hypoxia response. While the genetic basis of long-
term adaptation to hypoxia is well studied, we still have a limited understanding of the underlying genomic
regulation associated with plastic response to acute hypoxia. In addition, little is known about how the
duration and frequency of hypoxia exposure may play a role in such plastic and adaptive responses. Thus,
the working hypothesis of this proposal is that the plastic and adaptive response to hypoxia may vary
according to the amount of time an individual spends under hypoxic conditions. To test this hypothesis, we
will study birds residing across the elevational gradient in the Himalayas and Tibetan plateau that
demonstrate natural acclimation/adaptation to acute/chronic hypoxia. We propose two specific aims: the
first aim will quantify intra- and inter-species changes in hematological traits associated with chronic
hypoxia and study the genomics/transcriptomics profiles in low/high altitude residents and altitudinal
migrants to identify the underlying genetic basis of physiological traits associated with long-term adaptation
to hypoxia. The second aim will expose birds to their “non-native” elevation via transplantation experiments
and measure plasticity in hematological traits and gene expression profiles to identify gene regulatory
mechanisms associated with rapid acclimation to acute hypoxia. The proposed research is scientifically
important because understanding the genetic basis of acute and chronic hypoxia responses has implications
for human health. The data generated from the proposed study will provide critical insights into the genetic
factors associated with short and long-term hypoxia exposure that can be used to infer risk factors of
multiple diseases associated with hypoxia and identify potential targets for drug development.

Public health relevance
PROJECT NARRATIVE The public health burden of short and long-term hypoxia exposure can be significant, particularly in regions where large populations live at high altitudes. Understanding the genetic basis of acute and chronic hypoxia could lead to the development of new treatments and interventions to improve public health outcomes related to hypoxia exposure. Using birds from the Himalayas that are residing in their “native” altitude and those that will be experimentally exposed to “non-native” altitudes, we will quantify changes in physiological traits and their genomic/transcriptomic signatures, that can directly contribute to the mechanistic understanding of the underlying genetic basis of acute and chronic hypoxia.